Advancing Transplantation Tolerance in Nonhuman Primates

The Administrative Core
Abstract: The main objective of the Administrative Core is to facilitate the project’s
successful completion by organizing and coordinating the non-scientific aspects of the studies
that comprise this proposal. This program involves multiple institutions, academic departments,
industry organizations, facilities, and investigators. The Administrative Core will be responsible
for organizing and coordinating the regulatory requirements, administrative support structures,
financial models, standard operating protocols, sample analysis and data storage aspects of this
study. We will coordinate with the representatives from each institution to ensure that each
element of this core proposal provided to them in an efficient and organized manner. The
importance of Administrative Core lies in the fact that it will be the central interface that
bonds together each of the three projects. We believe that this bond will propel the projects
and cores to carry out the specific aims efficiently. Our past experiences, with clinical and
translational research consortia have led us to realize the importance of a strong administrative
core in order to achieve our scientific goals